Development and Testing of a Pediatric Cervical Spine Injury Risk Assessment Tool

Problem: Cervical spine injuries (CSI) are serious, but rare events in children. In contrast, use of spinal
precautions for trauma transport and radiographic evaluation for CSI in the emergency department (ED) are
common and associated with adverse effects. As a result, millions of children who have no CSI are exposed to
harm with no demonstrable benefit. The nation’s EMS systems need a Pediatric CSI Risk Assessment Tool
that can be used to reduce the number of children who are transported in spinal precautions and irradiated
unnecessarily. Leonard et al. and the Pediatric Emergency Care Applied Research Network (PECARN)
retrospectively identified 8 risk factors that predict CSI in children. We also established the infrastructure to
prospectively collect paired observations from EMS and ED providers and determined the test accuracies of
the PECARN CSI risk factors. Goal: We propose to develop and test a Pediatric CSI Risk Assessment Tool
that can be used by EMS and ED providers to determine which children warrant spinal precautions and
cervical spine imaging after blunt trauma. Specific Aims: Using prospective observational data and
information from a cognitive task analysis (ACTA) conducted with subject matter experts and relevant end-
users, we will use a user-centered design approach to 1) Develop the Pediatric CSI Risk Assessment Tool in
children with blunt trauma and 2) Validate the Pediatric CSI Risk Assessment Tool in a separate population of
children with blunt trauma; and 3) Validate the Pediatric CSI Risk Assessment Tool with EMS observations
from both the development and validation cohorts. Coordination: We will conduct this work at 15 PECARN
trauma centers. Methodology: We will collect prospective observational data from EMS and ED providers
regarding CSI risk factors for children who undergo emergency evaluation after blunt trauma and follow
enrolled subjects for 28 days to determine CSI status. The study will occur in two phases: development
(13,333 children; 240 children with CSI) and validation (8,889 children; 160 children with CSI). We will also
capitalize on the research infrastructure to conduct an ACTA and tool prototype testing that will inform the
iterative tool design to ensure that the tool is useable by EMS and ED providers. Evaluation: With data from
the development cohort, a useable clinical decision support tool will be constructed that achieves >95%
sensitivity, as well as adequate specificity (>40%) in the prediction of CSI. Subsequently, we will determine the
performance characteristics of the tool in the independent validation cohort and in a cohort that has EMS
provider observations. The ultimate output from this project will be a set of specifications for the Pediatric CSI
Risk Assessment Tool that will include a validated clinical decision rule, validated tool designs and functions,
and recommendations for implementation. Significance: An accurate, validated, and ultimately field-tested
Pediatric CSI Risk Assessment Tool will safely limit unnecessary spinal precautions and radiographic testing
for millions of children while helping identify those children who are truly at risk for CSI.

Public health relevance
Project Narrative: This project capitalizes on a pre-existing research network and established content-specific infrastructure to conduct a large, prospective observational study aimed at developing and testing a Pediatric Cervical Spine Injury Risk Assessment Tool. The project will also follow a user-centered design approach to ensure that the tool is useable and ready for rapid dissemination and implementation across the spectrum of health care providers that care for children that experience blunt trauma. Such a tool can be used to determine which injured children can be safely transported without spinal precautions in the prehospital setting and forgo radiographic evaluation in the emergency department. This project has the potential to benefit millions of injured children at negligible risk for cervical spine injury, but who are exposed to the harms of spinal precautions and/or neck irradiation.